One treatment, multiple targets: Prism adaptation and left brain stroke rehabilitation

Stroke is the most frequent cause of US adult disability, and post-acute stroke care is among
the fastest-growing expense categories. The functional disability experienced by Veterans after
stroke, and the limited rehabilitation resources available, highlight the importance of identifying
feasible treatments acting on more than one recovery target. Currently, cognitive and motor
impairments, and pain, are addressed with separate and modality-specific treatment pathways.
As a result, Veteran stroke survivors are vulnerable to a fragmented interprofessional care
process, with under-treatment of some disabling conditions and failure to coordinate synergistic
interventions. This fragmented care process leads to longer hospital stays, greater risk of falls
and accidents, incomplete recovery and poor quality of life. Our overall objective in this project
is to employ prism adaptation treatment (PAT), a 10-day regimen reported to enhance spatial
function, motor recovery, and reduce post-stroke pain. Although spatial-motor-sensory
impairments are common in both left and right brain stroke, previous studies of PAT have only
included right-brain stroke survivors. A potential barrier to broad implementation of PAT as a
multi-target treatment in stroke rehabilitation, is lack of evidence for the feasibility of assessment
and treatment procedures in patients with left-brain stroke who often experience co-morbid
language disorder (aphasia) and memory impairments. We propose the first study of PAT in
subacute left-brain stroke patients with aphasia and memory deficits to systematically
investigate the feasibility of using adapted PAT procedures (Aim 1) and adapted spatial-motor-
sensory assessments (Aim 2), which is a prerequisite to conducting a full-scale clinical trial.
Additionally, previous brain-mapping studies have shown that lesion patterns can be used to
identify patients who respond optimally to PAT. Thus, we also seek to establish a clinically
accessible, reliable way of categorizing lesion location (Aim 3), a prerequisite for broad
implementation of clinical guidelines about patient selection for PAT. In the proposed study, we
will collect and analyze data on four key areas of feasibility, including acceptability,
implementation, adaptation and limited efficacy. Our long-term goal is to implement PAT in both
left and right-brain stroke rehabilitation to simultaneously improve cognitive and motor function,
and pain. By demonstrating the feasibility of adapted assessment and treatment procedures in
left-brain stroke patients with aphasia and memory impairment, and the feasibility and reliability
of clinically accessible lesion categorization methods, we will open a path to a full-scale
investigation of PAT as a multi-target treatment stroke rehabilitation. This line of research has
the potential to increase the efficiency and effectiveness of currently fragmented care processes
and significantly improve functioning, independence and quality of life in thousands of Veterans
with stroke-related disabilities.

Public health relevance
Of the 15,000 Veterans who are hospitalized for stroke each year more than half experience spatial and motor impairments and pain. Spatial-motor-sensory problems limit functioning and independence, which is costly to Veterans, their families, and society. Currently, spatial-motor- sensory problems are targeted using different treatments. However, there is a treatment that has shown promise in simultaneously targeting spatial function, motor function and pain in right- brain stroke. We propose to investigate the feasibility of using adapted spatial-motor sensory assessment and treatment procedures for Veterans with left-brain stroke who have language and cognitive impairment. The next step will be to conduct a large-scale study focused on this multi-target treatment for more efficient and effective stroke rehabilitation. We expect this line of research to increase functioning, independence and quality of life in Veteran stroke survivors.